The impact of cholecystokinin on pancreatic beta-cell survival through paracrine and pharmacologic signaling

Diabetes affects nearly 1 in 4 Veterans receiving care from the VA. Reduced b-cell mass and increased b-cell
apoptosis are key to the pathophysiology of both type 1 and type 2 diabetes. Therefore, identifying factors that
can protect from b-cell apoptosis will meet a critical therapeutic need in the prevention and treatment of diabetes
in Veterans. Compensatory responses in b-cells allow adaptation to the stress of obesity, insulin resistance and
inflammation and can help preserve b-cell mass and prevent progression to diabetes. Our laboratory has dis-
covered that the hormone cholecystokinin (CCK) is produced in the pancreatic islet in response to metabolic
stress and can promote b-cell survival. Further, we find that CCK receptor (CCKR) agonist treatment of human
islets can significantly improve b-cell survival, supporting substantial translational relevance. The long-term goal
of my research program is to identify novel pathways critical in the preservation of b-cell mass. The overall
objective of this application is to determine how CCK expression and CCK receptor signaling impact islet home-
ostasis and b-cell survival. The central hypothesis is that CCK promotes functional b-cell survival. CCK-express-
ing islet cells may have reduced b-cell maturity, yet are critical to promote survival of neighboring b-cells through
paracrine signaling. To achieve the objective, three interconnected Specific Aims are proposed. In Aim 1, we will
identify the regulators of b-cell CCK expression in mouse and human islets under conditions of hyperglycemia
and cellular stress using both targeted and untargeted approaches. Preliminary evidence support the hypothesis
that GLP-1, cAMP, and glucose all contribute to CCK expression. In Aim 2, we will determine how CCK expres-
sion impacts islet cell identity, function and survival. We will use innovative experimental techniques, including
lineage-tracing mouse models, droplet-assisted RNA targeting single cell sequencing, and live cell imaging to
characterize and determine the impact of CCK-expressing cells in the islet. In Aim 3 we will investigate how
short-term incubation of human islets with CCKR agonists alters gene transcription and signaling pathways to
promote sustained b-cell survival. Additionally, we will determine the impact of CCK pretreatment on early human
islet graft survival after transplantation. Taken together our work supports the innovative concept of an intra-islet
signaling network whereby the non-classic hormone CCK promotes b-cell survival. As human islets have very
different characteristics than mouse islet, examining the role of CCK specifically in human islets is of critical
importance to translation of our findings to diabetes therapies. These studies will contribute to our fundamental
understanding of how b-cells respond to metabolic stress, as we propose that “de-differentiation” of a subpopu-
lation of b-cells will in fact allow production of non-canonical hormones that promote b-cell survival. This contri-
bution is significant as it will advance knowledge of both adaptive and therapeutic mechanisms of functional b-
cell survival, allowing development of targeted therapies with maximal efficacy and minimal side effects.

Public health relevance
Diabetes affects nearly 25% of Veterans, at rates much higher than in the general population. A key part of the pathogenesis of diabetes is the loss of function b-cells, partly through increased b-cell apoptosis. This project is relevant to the mission of the Department of Veterans Affairs in combating diabetes in Veterans by providing fundamental knowledge about novel pathways to protect b-cells from death.